Cross Training Core

PROJECT SUMMARY
Cancer is a major public health problem worldwide and is the second leading cause of death in the
US. Advances in our understanding of the biology of cancer have the potential to lead to
significant breakthroughs in cancer diagnosis, detection, and treatment. However, the translation
of basic science discoveries to clinical advancements has been slow and inefficient. The
translation of molecular insights from the lab to clinical trials and ultimately to clinical
practice relies on the close collaboration of scientists (radiation biologist and medical
physicist) and physicians (radiation oncologist) with relevant training backgrounds. A major
barrier to the integration of these basic scientists and physicians in translational settings is
the lack of enhanced mentored training opportunities focused on radiation biology workforce
development. To address the urgent need for well-trained independent investigators in cancer
research who can bridge the gap between scientific discovery and clinical advancement, we propose
the Cleveland Clinic Foundation (CCF)- Emory Cross-Training Program in ROBIN that will take
advantage of the outstanding resources, high caliber of investigators, and close collaboration
between cancer biologists, clinicians and physicists at the Cleveland Clinic Case Comprehensive
Cancer Center and Winship Cancer Institute of Emory University. The CCF/Emory Cross-Training Core
will provide a unique, individualized, and multi-faceted cross-training experience to support the
development of trainees (PhD and/or MD) in acquiring the knowledge and skills to address the most
important biological questions and clinically significant problems so that they can make
transformative discoveries to improve quality of care for patients with cancer. The primary
objective of the Cross-Training Core is to develop and sustain a collaborative environment that
encourages the center membership to increase interactions, sharing, and rapid adoption of
concepts and approaches. The cross-training core will establish and accelerate advances from
projects to paradigms by providing training and expertise with an overall trajectory that promotes
wider adoption by the oncology community to improve patient outcomes. We will operationalize the
mission of the cross-training core through integrated training opportunities for radiation
biologists, medical physicists, and radiation oncologists with the goal of engaging trainees in
research across the ROBIN Center’s multiple cores and projects. Building on a strong existing
culture of education and training, we propose the following specific aims: (1) Develop a
centralized radiation biology integration network to facilitate scientific cross- pollination
between radiation oncology, radiation biology, and medical physics within the ROBIN Center; (2)
Disseminate clinical / translational data from Cores, Projects, and Molecular Characterization
Trials across the center with the broader mission of fostering cross disciplinary training and
collaboration; (3) Develop a ROBIN center wide workforce development program relying on
interdisciplinary training for clinicians, physicists and
radiation biologists in translational radiation biology.